HIV and (Re)Emerging Viruses: Aligning Lessons Across Pandemics

ABSTRACT
Support is requested for a Keystone Symposia conference entitled HIV and (Re)Emerging Viruses: Aligning
Lessons Across Pandemics, organized by Drs. Melanie Ott, Priti Kumar, Olivier Schwartz and Alex Sigal. The
conference will be held in Hannover, Germany from April 8-11, 2024.
This Keystone Symposia conference brings together researchers studying HIV with those investigating
emerging and re-emerging viruses of global concern to advance knowledge on pathogenesis, evolution,
prevention, treatment, and long-term sequelae. The goal is to gain a better understanding of molecular
mechanisms and apply lessons learned from one outbreak to another with a focus on deploying recent
technological advances such as next-generation sequencing (NGS), gene editing, antibody, and mRNA
therapeutics to tackle emerging infections. This conference program includes sessions that will cover infections
such as HIV, SARS-CoV-2, monkeypox, Influenza, hemorrhagic fevers, among others. The influence of an
underlying HIV condition on other viral infections will also be discussed. This conference will feature speakers
from across the globe and bring together researchers who study a variety of viral infections, with an aim of
merging mechanistic and therapeutic insights gleaned from diverse pathogens to identify intersections and
potential opportunities in prevention and therapeutics related to HIV and other viruses. The unique intersection
of researchers and scientific topics of this conference, and the opportunities for informal cross-disciplinary
discussions, networking and mentoring interactions offer an unparalleled forum to advance virology research at
a critical time following on the recent COVID-19 pandemic.

Public health relevance
PROJECT NARRATIVE The global COVID-19 pandemic has had a profound impact on how scientists view the interconnectivity of viral infections, especially how an underlying HIV condition may influence an individual’s disease progression after exposure. Despite decades of research and therapeutic breakthroughs, there is still no cure for HIV, and many living with HIV are particularly vulnerable to infections from emerging and (re)-emerging viruses. This Keystone Symposia conference aims to bring together a diverse group of world experts on HIV and other viruses, like SARS-CoV-2 and Influenza, to identify collective research priorities, establish new partnerships and advance knowledge in virology alongside vaccine and treatment approaches with an aim to accelerate robust prevention and cure of viral diseases.